A total school approach using safeguarding to address HIV-related stigma and discrimination in boarding schools in Zambia

PROJECT SUMMARY
HIV-related stigma and discrimination operate at multiple socioecological levels and are known obstacles to
optimal health and HIV outcomes. In Zambia, some boarding school environments can be characterized by a
culture of physical, verbal, and sexual abuse strongly linked to stigma and discrimination. Despite this, little
data exists on the impact of HIV-related stigma or stigma reduction interventions within school settings, with
even less attention to boarding schools. This study responds to the challenges of making Zambian boarding
schools safe, stigma-free havens with reduced risk behaviors and improved health outcomes for learners,
teachers, and support staff – both those living with HIV and those who are not. Building on evidence that
addressing HIV stigma and discrimination can disrupt the cycle of violence that is both cause and
consequence of HIV risk and vulnerability, this study’s objective is to pilot test and evaluate a ‘total school
approach’ to addressing HIV-related stigma and discrimination in boarding schools, embedded in a
safeguarding framework. We will co-create stigma reduction intervention packages with learners, teachers,
staff, people living with HIV and other key stakeholders at two boarding schools in Zambia. Learners, teachers,
and staff will be trained to then deliver trainings to at least 80% of each school’s population. For Aim 1, we will
conduct a formative phase to adapt a ‘total facility approach’ for addressing stigma and discrimination in
healthcare to the Zambian boarding school setting, and to co-create an intervention package, that uses a
safeguarding approach, with the participating school communities. For Aim 2, we will carry out a paired pre-
post study to pilot test the impact of the intervention on stigma and discrimination and broader safeguarding
measures. We will implement a pre-post study design with outcomes measured through repeat paired surveys
before and after the intervention. For Aim 3, a mixed-methods process evaluation will explore how the school
environment affects its population’s attitudes and behaviors and seek to understand implementation barriers
and facilitators with a view to informing sustainability and scale-up. The primary outcome measures will be self-
reported experience of abuse and stigmatizing attitudes relating to HIV. Mixed-methods approaches will
provide insight into why different elements of the intervention worked/did not work and maximize learning about
implementation of this approach to fostering a safe school environment, free from stigma and discrimination so
as to improve HIV-related outcomes.

Public health relevance
PROJECT NARRATIVE Physical, verbal and sexual abuse documented in boarding schools in Zambia are strongly linked to stigma and discrimination and heighten HIV stigma experiences for those affected by HIV both at school and beyond; given the impact of HIV-related stigma and discrimination on HIV-related outcomes, there is a compelling need for HIV stigma reduction in boarding schools within a broader context of safeguarding to foster deeper acceptance of HIV. This study seeks to adapt the ‘total facility approach’ to addressing HIV-related stigma and discrimination in healthcare settings and pilot-test it in boarding school communities, including individuals living with HIV and individuals who are not. Intervention packages will be co-created with school stakeholders and will target learners, teachers, staff, and staff from nearby healthcare facilities to create a community of safety characterized by reduced experiences of HIV-related stigma and abuse so as to lower barriers to engagement in care within the boarding school setting and equip young people with skills to better navigate HIV.